Assessing Parenting at the Momentary Level to Understand Parenting Behaviors that Contribute to Improved Treatment Outcomes for Youth with Co-Occurring Disorders

PROJECT SUMMARY/ABSTRACT. Over 80% of adolescents with an alcohol use disorder (AUD) who
present to treatment have a co-occurring psychiatric diagnosis. Although the best available treatments for
adolescents with alcohol use disorders and co-occurring disorders (AUD+CODs) yield only modest short-term
benefits, parent-involved treatments result in the best outcomes. In line with NIAAA’s strategic plan to improve
treatments for AUD+CODs, this application seeks to address a central, yet unanswered question – what
parenting behaviors during parent-involved treatment for AUD+CODs contribute to improved outcomes?
Parenting is dynamic and varies from moment to moment depending on context, affect, and adolescent
behavior. Moreover, treatment motivation, alcohol craving, alcohol and cannabis use, and internalizing and
externalizing symptoms — core adolescent AUD+CODs treatment targets — vary considerably within and
across days. Understanding the parenting behaviors during treatment that account for improved treatment
outcomes requires momentary assessments that can capture the dynamic nature of parenting and core
adolescent treatment targets. This K99/R00 study intends to leverage an experimental medicine framework to
study how parenting, captured in real time in daily life, impacts core treatment targets (treatment motivation,
alcohol craving, alcohol, and cannabis use, and internalizing and externalizing symptoms) among adolescents
enrolled in an intensive outpatient for AUD+CODs. The specific aims for the K99 are to adapt parental
communication, general parenting practices, and alcohol-specific parenting measures to EMA (Aim 1), conduct
a pilot feasibility and acceptability study of the EMA protocol (N=20 parent-adolescent dyads; Aim 2a), and use
mixed methods to evaluate and refine the EMA parenting measures and protocol (Aim 2b). Dr. Samuel
Meisel’s overarching training goals are to (1) refine skills in independently designing, developing, and
executing EMA research (Drs. Robert Miranda and Elizabeth McQuaid), (2) solidify expertise in conducting
treatment research with adolescents with AUD+CODs (Drs. Aaron Hogue and Robert Miranda), (3) apply
experimental medicine methods to adolescent AUD+COD treatment mechanisms research (Dr. John Kelly),
and (4) promote a successful transition to independent faculty researcher. These training objectives build on
Dr. Meisel’s F32 (AA028414), which provided him with the foundational training to broaden his research from
studying the initiation and escalation of adolescent alcohol use to adolescent alcohol use treatment and
mechanisms of behavior change. R00 specific aims include examining momentary parenting-core treatment
target associations (N=75 parent-adolescent dyads; Aim 3a) and examining changes in the strength of
parenting-treatment target associations over the course of AUD+COD treatment (Aim 3b). Findings will
systematically identify the specific parenting practices during AUD+CODs treatment that most strongly relate to
core treatment targets and will serve as preliminary data for future R01 and R34 applications.

Public health relevance
PROJECT NARRATIVE Although parent-involved interventions for adolescent alcohol use disorder and co-occurring disorders results in the best outcomes, our understanding of the parenting behaviors during treatment that improve outcomes remains at a nascent stage. The goal of this K99/R00 is to examine parenting practices (parental communication, general parenting practices, and alcohol-specific parenting practices), in real time in daily life, and their associations with adolescent core treatment targets (e.g., treatment motivation, alcohol craving and use) throughout evidence-based parent-involved treatment for co-occurring disorders. By identifying the parenting behaviors that most strongly relate to core treatment targets during treatment, results from this project will provide critical information to facilitate the development of brief, scalable, parent-involved interventions.